Elucidation of Integrator's Function

Project Summary
Integrator is a multi-protein complex stably associated with the C-terminal domain (CTD)
of RNA polymerase II (RNAPII). Integrator contains a catalytic RNA endonuclease
subunit (INTS11) with high degree of homology to cleavage and polyadenylation
specificity factor 73 (CPSF73), the enzyme responsible for cleavage and termination of
messenger RNA (mRNA) genes. We showed that Integrator RNA processing activity is
not only required for noncoding genes but also for protein coding genes facilitating
transcriptional elongation. In this proposal, Aim 1; Will detail the mechanism of the
Integrator regulation of 3’-end processing and termination of protein coding genes. In
Aim 2; We will explore the role of the Integrator complex in regulation of inflammatory
gene expression program following our discovery of cooperative association of Integrator
with RELA, a component of canonical NFkB complex. These findings expand the role for
Integrator in stress signaling and immune system. Finally, in Aim 3; We will elucidate the
function of a new trimeric complex composed of INTS11-INTS9 and BRAT1 protein, a
gene mutated in human developmental syndromes causing rigidity and multifocal
seizure syndrome in neonates and neurodevelopmental disorders.

Public health relevance
Project Narrative Beyond its role in noncoding RNA processing, we find Integrator, an RNA polymerase II- associated complex, regulates the 3’-end processing and termination of a set of protein coding genes. Unexpectedly, we further uncover a role for Integrator in regulation of NFκB signaling, a critical mediator of inflammatory response. Our studies will provide fundamental insight into regulation of gene expression, which will be the basis for development of rational therapies against pathogenic gene expression.